Decoding the Paradox of DDX41-mutant MDS

Project Summary
Inherited mutations in the RNA helicase gene DDX41 cause predisposition to adult-onset Myelodysplastic
Syndrome and related myeloid malignancies, accounting for up to 5% of MDS cases. These mutations are
always heterozygous and are often frameshifts in the N-terminal region of the protein, suggesting that they cause
loss of protein function. The DDX41 protein has described functions in mRNA splicing, innate immune signaling
and ribosome biogenesis, but the precise mechanism by which DDX41 mutations contribute to myeloid
malignancy is not understood. In approximately 70% of MDS patients with germline DDX41 mutations, a mutation
in the other allele of DDX41 is acquired in the diseased bone marrow (BM) cells. This somatic mutation almost
always causes the specific amino acid substitution Arginine-525 to Histidine (R525H). In a recent publication,
we demonstrated that murine hematopoietic stem and progenitor cells (HSPC) bearing two loss-of-function
Ddx41 mutations (Ddx41-/-) or one loss-of-function mutation and one Ddx41R525H mutation (Ddx41R525H/-) undergo
cell cycle arrest and apoptosis. This indicates that one copy of wild-type DDX41 is required for hematopoiesis
and that the R525H mutant is deficient for the required function. In our mouse model, we found that hematopoietic
stem cells (HSC), which are mostly quiescent, can survive with biallelic Ddx41 mutations but do not expand in
vivo. These findings raise an apparent paradox in that the precise combination of DDX41 mutations that is
present in many patients is selected against in the proliferative HSPC pool and thus clones bearing these
mutations would be unlikely to survive and expand sufficiently to contribute to disease. Our proposed studies will
elucidate the mechanistic basis of selection for the acquired DDX41R525H mutation in germline DDX41-mutant
patients. Our overall hypothesis is that HSC, which have obligatory low protein translation activity, are the cell
type in which DDX41R525H mutations arise, persist, and expand due to decreased function of the DDX41 protein
causing reduced ribosome synthesis. The selection for DDX41R525H mutant HSC, possibly with the assistance of
other co-mutations, causes hematopoietic inefficiency due to the limited proliferative capacity of their
differentiating progenitor cells, leading to MDS. The inability of Ddx41R525H/- mouse HSC to expand in BM
necessitates examination of patient cells bearing this combination of mutations to understand how they survive
and expand. Using single-cell sequencing approaches, we propose to analyze MDS patient BM cells to
determine the differentiation state, transcriptomic changes, and co-mutations present in cells bearing the
acquired R525H mutation. To determine the molecular basis for the selective advantage of cells bearing the
R525H mutation, we will use genetically-engineered cell models to quantitatively assess the function of the
R525H mutant protein compared to wild-type. With an improved understanding of the effect of acquired DDX41
mutations on MDS pathogenesis, we will then test genetic or chemical inhibitors of rationally-chosen targets for
therapeutic eradication or mechanistic rescue of HSPC bearing biallelic DDX41 mutations.

Public health relevance
Project Narrative Inherited and acquired mutations in the gene DDX41 are frequently coincident in the bone marrow of Myelodysplastic Syndrome patients. Animal and cellular models indicate that this combination of mutations causes cell cycle arrest and apoptosis, eliciting the question of how these cells arise and expand in patient bone marrow to cause disease. In this project, we will analyze MDS patient bone marrow by single cell sequencing approaches and then quantitatively assess the effect of the most commonly observed acquired DDX41 mutation on protein function to elucidate the precise mechanism by which cells bearing biallelic DDX41 mutations contribute to MDS pathogenesis.